VASCULAR CELL BIOLOGY CONFERENCE

DESCRIPTION: (Adapted from the application) During the past several years, our knowledge of the vascular system has been dramatically increased as has been our ability to manipulate genetic material and cell behavior. Several aspects of vascular cell biology have undergone substantial growth and development and, in a parallel fashion, several new technologies and methodologies have been applied to the study of vascular biology. This application is a request for funds to partially support an interdisciplinary, international conference on Vascular Cell Biology which will serve to bring together investigators, post-doctoral fellows, and graduate students from diverse fields of study for five days of intense discussion and study. This conference will be the sixth Gordon Conference on Vascular Cell Biology and is to be held at Plymouth State College on June 28 - July 3, 1998. The focus of this conference will be on the mechanisms used by vascular cells to interact with their local environments and mechanisms used by vascular cells to modulate their growth. The conference will be a major vehicle for integration of new knowledge in the field and will lead to better understanding of the cell and molecular biology of the vessel wall. The planned sessions and their tentative chairs are as follows: Angiogenesis: Dr. D. Cheresh ( Scripps); Vascular Development: Dr. W. Risau (Max Planck Inst., Bad Neuheim, Germany.); Vascular growth, death and remodeling: Dr. V. Dixit (Univ. of Michigan): Cell: cell and cell matrix adhesion: Dr. M. Ginsberg (Scripps); Leukocyte-endothelial interactions: Dr. M. Gimbrone (Harvard); Receptors and paracrine signaling: Dr. P. Libby (Harvard); Proteases: signaling and motility: Dr. S. Coughlin (Univ. of California, San Francisco); Gene targeting and therapy: Dr. J. Rossant (Samuel Lunenfeld Research Inst., Mt. Sinai Hospital, Toronto, Canada).